INFLUENCE OF CHRONIC DAILY BISPHOSPHONATE THERAPY ON ATHEROMATOUS PLAQUE

In bone, the bisphosphonates act as phosphate surrogates. They are complexed with calcium in the hydroxyapatite matrix and, once incorporated into the mineral phase of bone, act to inhibit osteoclastic bone resorption. Because there are "dedicated" matrix-resorbing cells in plaque as there are in bone, we postulate that bisphosphonates associated with the hydroxyapatite matrix of mature atherosclerotic plaque will have a similar effect on the accumulation of calcified matrix in plaque as they do in bone. Based on this assumption, we are examining the potential for alendronate 1 a bisphosphonate to accelerate the calcification of arterial plaque as assessed by ultra-fast CT of the heart and aorta.